DISCONTINUATION OF MECHANICAL VENTILATION ON HEMODYNAMICS

The goal of this study is to determine the hemodynamic (HD) effects of the change from receiving mechanical ventilation (MV) to that of spontaneous breathing (SB) in critically ill children.